Redox stress responses in Clostridium difficile: mechanisms and implications

? DESCRIPTION (provided by applicant): The overall goal of this proposal is interrogate gastrointestinal (GI) niche establishment of the diarrheagenic pathogen, Clostridium difficile. We have identified a unique oxygen detoxifying enzyme, superoxide reductase (SOR), which promotes C. difficile survival in the GI tract. The immediate impact of this work will be to validae SOR and other redox proteins as novel targets for interventions designed to prevent C. difficile colonization. Three Specific Aims are proposed. In Aim 1, we will delineate the impact of oxygen and reactive oxygen species (ROS) exposure on C. difficile localization and survival in the GI tract. In Aim 2, we will assess the impact of host ROS deficiency on C. difficile niche establishment. In Aim 3, we will comprehensively map the C. difficile redox-stress response compendium. All the proposed studies will use recent clinical isolates of C. difficile that we have obtained through ongoing disease surveillance studies. For Aims 1 and 2, two animal models will be employed, and bacterial establishment tracked via live-animal and ex vivo imaging using a novel colonization tracer we have specifically developed for these studies. For Aim 3, we will employ next-generation redox proteomics (ROSics) approaches.

Public health relevance
PUBLIC HEALTH RELEVANCE: Hundreds of thousands of cases of Clostridium difficile infection (CDI) occur annually in the USA, imposing a burden of >$3 billion on the healthcare system. CDI now surpasses all other bacterial infections in many US hospitals. The studies proposed in this application are focused on understanding how C. difficile, a strictly anaerobic bacterium, combats oxygen exposure as it transits through the mammalian gastrointestinal tract. The findings from this study will directly support future efforts to identify chemical inhibitors tat target C. difficile's oxygen tolerance proteins, and thus prevent gut establishment of this recalcitrant and notorious pathogen.